Alterations and Renovations

PROJECT SUMMARY
The University of Hawaii (UH) provides institutional support for research using animal models of human health
and diseases through the operation of two vivaria, one in the Biomedical Sciences Building (Biomed) on the UH
Manoa campus and the other in the John A. Burns School of Medicine (JABSOM) Biosciences Building in the
Kaka’ako campus. Currently, the Kaka’ako Vivarium holds one metabolic cage system in the Metabolic
Phenotyping Core Facility. We aim in this A&R proposal to improve the Biomed Vivarium, via obtaining major
replacement equipment for Vivarium operations and conduct HVAC testing and balancing; and to obtain
metabolic cage systems to expand the Metabolic Phenotyping Research Facility to the Biomed vivarium.
Expanded and improved animal facilities and adjacent laboratory and office space will not only increase research
capacity in the Precision Nutrition at UH but will foster new interdisciplinary collaborations between researchers
from different departments and disciplines across the UH System campuses.